The CD226 costimulatory axis in type 1 diabetes

ABSTRACT. Type 1 diabetes (T1D) results from complex interactions between over 150 independent loci
imparting disease susceptibility and environmental factors that break immune tolerance, leading to the immune-
mediated destruction of insulin-producing pancreatic -cells. Among these exists a small number of coding
variants, which may represent rational therapeutic targets to restore immune tolerance, yet the cellular and
molecular mechanisms by which risk variants alter immune function remain poorly characterized. The CD226
candidate gene contains a protein coding variant (rs763361) linked to multiple autoimmune disorders, including
T1D. CD226 functions as a costimulatory molecule that competes with the negative regulators, TIGIT and CD96,
for binding to CD155 or CD112 expressed on antigen presenting cells (APCs). Our published and preliminary
data, supported by the initial phase of this R01, suggest that CD226 signaling destabilizes the regulatory T cell
(Treg) phenotype. Specifically, genetic deletion of Cd226 attenuated disease development in the non-obese
diabetic (NOD) mouse model of T1D, both in genomic knockout (gKO) and Treg-specific conditional KO (cKO)
lines, with reduced ex-Treg frequency in the pancreatic lymph nodes (pLN) of gKO animals. Moreover, CD226–
human Tregs display increased purity, stability, and suppressive function. Single-cell transcriptional profiling and
flow cytometric analysis of tissue-resident T cells isolated from T1D organ donor pancreas and pLN identified an
imbalance of CD226 and TIGIT expression on CD8+ T cells. We hypothesize that the T1D-associated risk
variant in CD226 results in immune checkpoint dysregulation that leads to defects in peripheral immune
tolerance, specifically resulting in Treg instability prior to T1D onset. To test this, we propose three Specific Aims.
1) We will perform single cell multi-omic profiling and adoptive transfer studies to identify the cellular and
molecular basis by which CD226 contributes to defective immune tolerance in the NOD mouse, using our Cd226
gKO and Treg cKO strains. 2) We will assess the expression profile and functional impact of the CD226 risk
variant using banked organ donor tissues and human peripheral blood samples derived from individuals with
and at risk for T1D. These efforts will involve in situ profiling of genotype-selected pancreas and pLN samples
via spatial transcriptomics and high-content imaging, along with CRISPR/cas9 gene-editing of CD226 in primary
cells with T cell receptor (TCR) gene transfer to generate isogenic, autoreactive Treg, CD4+, and CD8+ T cells
for in vitro functional studies. 3) We will test candidate therapeutics targeting the CD226 costimulatory axis in
vivo using NOD mice and in vitro using human cells. Hence, the proposed studies will employ novel animal
strains along with gene editing and TCR gene transfer techniques in human lymphocytes, which we pioneered
over the prior grant term, to inform on the contributions of the CD226/TIGIT/CD96:CD155/CD112 immune
checkpoint to T1D development, with the potential for translatable interventions blocking CD226 co-stimulation
to halt the immune-mediated destruction of pancreatic -cells.

Public health relevance
PROJECT NARRATIVE The modern era of molecular biology has revealed key variants throughout the genome that are enriched in those who develop complex autoimmune diseases, including type 1 diabetes (T1D). Our goal is to understand how these variants in immune checkpoints contribute to a loss of immune tolerance to pancreatic -cells, and toward that objective, this R01 renewal application is centered on CD226, a gene encoding a costimulatory molecule associated with T1D genetic risk and disease development. The results of this project are expected to inform on the biological mechanisms by which CD226 signaling alters peripheral tolerance and contributes toward disease progression, as well as provide preclinical data related to therapeutic targeting the CD226/TIGIT/CD96:CD155/CD112 pathway to correct immune defects and restore immune tolerance.